Development of Therapeutic Candidates for Antibiotic Resistant Bacteria

To support the advanced development of candidate therapeutics for antibiotic resistant pathogens. The supported research and development activities will progress the therapeutic product development and may include lead optimization, candidate selection, preclinical and IND enabling studies, Chemistry, Manufacturing, and Controls (CMC), IND submission, clinical safety and efficacy assessment.